A deep learning algorithm to detect signs of cognitive impairment in electronic health records

Alzheimer’s Disease and Related Dementias (AD/ADRD) outcomes from real-world data, such as electronic
health records (EHR), offer the possibility of examining a wide variety of research questions that cannot be
answered efficiently—or at all—in other settings. A key challenge is that AD/ADRD is under-recognized in the
community, under-diagnosed by healthcare professionals, and under-coded in claims data—and can be
mislabeled in any setting. Thus, approaches relying on dementia diagnosis codes or medications suffer from
inaccuracies in these data. EHR has a wealth of information in clinical notes, patient health history, and health
system interactions that often contain signs of cognitive decline. Deep learning algorithms can leverage and
learn from these complex text and data patterns in EHR. In this proposal, we aim to develop and evaluate a
deep learning algorithm to improve the detection of cognitive impairment due to underlying AD/ADRD
pathophysiology (including cognitive concerns, mild cognitive impairment, and dementia) using the EHR of
three large healthcare institutions. For training and evaluation of the algorithm, we will use a “seed” reference
standard set with detailed chart review and adjudication of cognitive diagnosis by an expert clinician (n=1,000),
and then apply active learning strategies with diversity sampling to better reflect the characteristics of US older
adults and iteratively increase sample size to n=20,000. We will rigorously evaluate the algorithm using EHR
from all three institutions, and develop openly available guidelines and resources for the research community.
Our specific aims are: 1) To develop and evaluate a deep learning NLP tool to identify patients with cognitive
impairment using EHR at one institution; 2) To refine and evaluate the performance of our EHR deep learning
algorithm at two other healthcare institutions; and 3) To develop open guidelines, resources, and tools for EHR
data use in dementia research. We will measure the marginal improvement in accuracy of our deep learning-
based classification relative to models based on diagnosis codes and medications alone, and characterize the
predictors of poor model performance, both to improve the model and to understand potential biases. As such,
our tool will provide a better understanding of the limitations of using diagnosis codes and/or medications in
dementia research. Cutting-edge deep learning algorithms have been applied to many real-world tasks but in a
limited manner to AD/ADRD. We anticipate that our state-of-the-art deep learning algorithm, which will be
rigorously developed and validated with large representative datasets at multiple institutions, will more
efficiently and accurately detect signs of cognitive impairment and can be readily deployed by practitioners.
Improved screening of cognitive impairment in EHR will enhance dementia research studies and enable large-
scale pragmatic trails. In the future, we hope, the proposed tool will also be useful in clinical settings to flag
patients with cognitive impairment who could benefit from an evaluation or be referred to specialist care.

Public health relevance
PROJECT NARRATIVE Dementia is a growing healthcare problem and a research priority. Studies using real-world data—such as electronic medical records—offer the possibility of enabling large pragmatic trials and research studies, but correctly identifying patients with dementia in these data remains a challenge. We will apply state-of-the art technology and perform rigorous validation across multiple healthcare institutions to improve the detection of patients with cognitive impairment within medical records, which will not only facilitate research but may also aid providers in planning and managing patient care.